Digitally Enhanced Cognitive-Behavioral Therapy for Adolescents with Depression and Obesity

Project Summary/Abstract
Adolescent depression is a major public health problem that has serious consequences for cardiometabolic
disease, predicting heightened risk for glucose dysregulation, type 2 diabetes onset, and cardiovascular events.
Evidence-based interventions such as cognitive-behavioral therapy (CBT) to decrease depression in
adolescents with elevated body mass index (BMI ≥85th%ile for age/sex) are anticipated to improve
cardiometabolic health, in part by ameliorating the negative impacts of depression on health behavior (e.g.,
physical activity, eating, and sleep). Our preliminary studies provide support for this overarching hypothesis. We
have shown that a relatively brief, 6-week/6-session CBT-group decreased depression at post-intervention and
lowered indicators of insulin resistance at 1-year follow-up among racially/ethnically diverse (70% Black/
Hispanic) adolescents (12-17y) with depression (CES-D: Center for Epidemiologic Studies-Depression Scale
≥21) and elevated BMI (≥85th%ile), compared to a time/attention-matched health education control group
(K99/R00HD069516). Decreases in depression explained health benefits and were linked to increases in
adolescents’ frequency/enjoyment of physical activity. However, effect sizes were small-to-moderate (Cohen’s
d=.39-.61), possibly due to less-than-optimal (~60%) home practice in between sessions. Homework completion
tracks with treatment effects in our team’s and others’ studies, likely because homework facilitates skills
acquisition in daily life. In qualitative focus groups after CBT-group, adolescents with depression and elevated
BMI express a desire for digital technology support of homework completion (R01AT011008). Few empirically-
supported digital apps for depression exist for adolescents, much less adolescents with elevated BMI. Yet, our
overarching rationale is that enhancement of CBT-group with a digital app is likely to strengthen translation of
CBT skills to healthier coping and behavior, leading to stronger improvements in cardiometabolic health than
CBT-group alone. In this NHLBI R34, we will leverage mobile health (mHealth) to adapt an existing CBT-digital
app for the distinct needs/preferences of adolescents with depression and elevated BMI and optimize the app’s
integration with CBT-group virtual sessions. In Phase 1, we will gather input from adolescents, caregivers, and
healthcare providers through semi-structured focus group discussions (N=30), yielding an adapted app (Aim 1).
In Phase 2, we will iteratively refine the app through user-centered, mixed methods input in a single-arm, open
trial (N=10) of CBT+ (virtual group + adapted app), until feasibility/acceptability benchmarks are met (Aim 2).
Phase 3 is a pilot randomized controlled trial of CBT+ vs. virtual CBT-group only to assess protocol/intervention
feasibility/acceptability (Aim 3). An interest holder working group will work with researchers to apply feedback
from diverse perspectives at all stages. Completion of the aims will provide necessary and sufficient information
to proceed with a rigorous efficacy study of CBT+. This research directly aligns with NHLBI’s interest in promoting
cardiovascular/cardiometabolic health in early stages of the lifecourse such as adolescence (NOT-HL-21-020).

Public health relevance
Project Narrative The proposed research is highly relevant to public health because pilot studies that contribute to the development of mobile health (mHealth) and digital technology to decrease depression in adolescents with overweight/obesity offer the prospect of mitigating cardiovascular and cardiometabolic disease risk. Adolescents from historically disadvantaged racial/ethnic and socioeconomic backgrounds disproportionately experience depression and earlier lifecourse-onset of cardiovascular and cardiometabolic diseases. By rigorously incorporating interest holder input in the adaptation of a digital app to enhance group cognitive-behavioral therapy for adolescents with depression and overweight/obesity, the proposed research is poised to contribute to the NHLBI’s mission to combat cardiovascular and cardiometabolic health disparities and improve people’s health and quality of life.